A non-viral gene editing platform for cell therapies and translational autoimmune disease modeling

SUMMARY
Gene edited T lymphocytes hold promise as safe and effective living therapies for a wide range of human
diseases, including autoimmune disease. However, viral methods currently employed to engineer cells for
therapy are imprecise, exorbitantly expensive, and have high failure rates. These drawbacks limit development
of cell therapies and prevent them from penetrating alternative markets, where natural, spontaneous disease
can be addressed in pre-IND and IND-enabling studies to improve therapeutic outcomes.
This proposal is focused on optimizing and advancing the development of a novel, non-viral method for highly
efficient and precise engineering of human T cells. The innovation is a nanoplasmid-based, site-specific gene
editing platform that enables tunable manufacturing of human cell therapeutics. Not only will this precise gene
editing platform yield a quantum leap forward in cellular engineering, but the resultant product will also provide
sustained clinical improvements over the standard of care for B cell–mediated autoimmune diseases, for which
no current cell therapies exist. This Phase I proposal is focused on optimizing the efficiency of the GeneWeld
site-specific gene editing platform and demonstrating the in vitro functionality of using GeneWeld to reprogram
human Chimeric Antigen Receptor (CAR)-T cells for elimination of a targeted B cell population.

Public health relevance
NARRATIVE No precise, plasmid-based, non-viral gene integration platform has achieved scalable, efficient manufacturing for human cell therapies. This proposal is focused on fulfilling this unmet need with the development of a safe, non-viral, targeted, and highly efficient genome editing platform for ex vivo programming of primary human T cells (e.g., CAR-T cells).